Mechanisms of Parp inhibitor-induced bone marrow toxicities

PROJECT SUMMARY
Poly-(ADP ribose) polymerase (PARP) inhibitors as a drug class are considered one of the great success
stories of Precision Medicine with Food and Drug Administration drug approvals accumulating for growing
proportions of patients with diverse cancer types. As well, preclinical studies are investigating their use in a
multitude of non-malignant diseases. These drugs inhibit multiple PARP enzymes at once, some of which are
critical enzymes for sensing and coordinating repair of several types of DNA damage. Further, these drugs trap
the PARP1 enzyme onto DNA, resulting in a DNA double strand break to resolve this lesion. Thus, by design,
these drugs increase DNA damage in cells, raising concern that they could be toxic to or even mutate normal
cells that rely on PARP enzymes for their functions. Thus, clinical trial and drug safety databases showing serious
bone marrow adverse effects, including severe, and sometimes irreversible lowering of the blood counts, and an
increased risk of deadly therapy-related bone marrow cancers suggest that hematopoietic stem and progenitor
cells are uniquely susceptible to PARP inhibitor effects. However, mechanism and causation are not yet clear.
The long-term goal is to understand normal bone marrow function and if patients with germline or
acquired mutations in their bone marrow cells are uniquely susceptible to the adverse effects of specific
exposures. The central hypothesis is that 1) PARP inhibitors, due to their ability to stall replication forks and
cause double strand DNA breaks, impair hematopoietic stem and progenitor cell proliferation, resulting in
decreased blood cell production from the most proliferative subsets more than others., and that 2) these PARP
inhibitor effects mobilize long-term stem cells to help meet blood production demands and at the same time
create a competitive environment in which stem cells with TP53 or other mutations are favored to outgrow wild-
type, but ultimately predisposing patients to bone marrow failure or leukemia. The rationale for this project is that
an ever-expanding group of patients are being treated with PARP inhibitors and many experience serious blood
and bone marrow toxicities, including development of therapy-related blood cancers, but the mechanism and
methods to prevent these serious toxicities are not known. Using mouse and human in vitro and in vivo models,
we will test these hypotheses with the following specific aims: 1) Determine how PARP inhibitors disrupt normal
hematopoiesis to cause cytopenias; and 2) Determine whether PARP inhibitors create a selective environment
and unmask fitness differences in hematopoietic stem and progenitor cells with varying genotypes or are able to
mutate these cells on their own.
The research proposed in this application is innovative because it is the first study to determine how
inhibiting multiple PARP enzymes simultaneously impacts normal hematopoiesis on a mechanistic level. This
proposal is significant because it will allow identification of prevention strategies for safe PARP inhibitor use and
of new drug targets for improving hematopoiesis via PARP enzyme manipulations.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on understanding how a class of drugs called PARP inhibitors, drugs being used to treat cancer and being tested for an expanding number of non- malignant human diseases, cause the serious blood and bone marrow toxicities seen in some patients taking them. This proposal will provide key mechanistic insight into which cells in the bone marrow require the enzymes targeted by these drugs for normal functioning, and whether these drugs have the capability to mutate the DNA of these cells to predispose patients to bone marrow failure or blood cancers. Thus, the proposed research is relevant to the National Heart, Blood, and Lung Institute’s mission to promote the prevention of blood diseases and enhance the health of all individuals so that they can live longer and more fulfilling lives.